Shared Resource Management

SHARED RESOURCE MANAGEMENT (SRM): PROJECT SUMMARY
The overarching goal of the Georgetown Lombardi Comprehensive Cancer Center (LCCC) Shared Resource
Management (SRM) is to ensure LCCC Members across the Consortium have access to cutting-edge
technologies, exceptional staff, and quality services to enable high-impact cancer research and scientific
interaction and productivity. The LCCC Shared Resources (SRs) are directed by Stephen Byers, PhD, Associate
Director (AD) for SRs since 2005. In 2019, LCCC was awarded consortium status with the John Theurer Cancer
Center (JTCC) of Hackensack Meridian Health (HMH) in New Jersey (NJ), and the SR activities broadened to
serve investigators at both LCCC campuses. Byers is supported by two highly qualified SR Administrative
Directors: David Goerlitz, MS (DC), and Steven Park, BS (NJ) to ensure that SRs meet LCCC Member needs.
LCCC currently has nine SRs: Animal Models; Biostatistics & Bioinformatics; Flow Cytometry & Cell Sorting;
Genomics & Epigenomics; Histopathology & Tissue; Mass Spectrometry & Analytical Pharmacology; Microscopy
& Imaging; Survey, Recruitment, & Biospecimen Collection; and Tissue Culture & Biobanking. SRM oversees
SR budgets and operations to ensure access, prioritization, and integration of state-of-the-art services and
technologies across the Consortium. SRM carries out annual surveys to assess SR user satisfaction and gather
suggestions regarding new services/instruments. Byers chairs the LCCC SR Oversight Committee, which meets
quarterly and is comprised of Scientific Leaders and representative LCCC Members and provides
recommendations regarding SR space, resources, policies, and procedures. Each SR has a specific SR Advisory
Committee (SRAC) consisting of representative users and SR-specific experts from both LCCC campuses that
meets at least annually to provide oversight of SR services, usage, user satisfaction, personnel, and finances.
Byers actively participates in the LCCC Senior Leadership and Executive Committees to provide strategic input
and ensure SR alignment with the Center’s programmatic research activities and priorities. During the current
project cycle, SRM accomplishments include managing the acquisition and installation of new equipment ($12.3
million) and a biorepository LIMS system (OpenSpecimen), the introduction of NJ-based pharmacokinetics,
pharmacodynamics and mass spectrometry imaging services to form the new MSAPSR, expansion of the
zebrafish facility, an S10-supported small animal MRI, and the development of multiple Spatial Biology
applications. SRs provided a broad range of services to all three LCCC Research Programs, supporting the
cancer research activities of 90 LCCC Members, including 17 based in NJ, and directly contributing to 263 peer-
reviewed publications, 50 of which appeared in high-impact journals (IF ≥ 10), and 225 peer-reviewed
extramurally funded research grants.